Personalized Dietary Management in Type 2 Diabetes

Abstract
Hyperglycemia in type 2 diabetes (T2D) is associated with a variety of vascular complications of the disease, but
clinical trials of medication regimens designed to achieve near-normal HbA1c have been disappointing and may
even increase the risk of adverse outcomes due to polypharmacy. Enhancing behavioral management of
postprandial glycemia can further reduce glycemic exposure and downstream effects without the risks of
polypharmacy. Postprandial glycemia is largely driven by dietary intake, but research findings regarding the best
dietary approach to limit glycemic exposure are mixed and mostly negative. Studies done, to-date, have used
one-size-fits-all dietary regimens that do not take into consideration the fact that glycemic response is highly
individual. In this clinical trial of 255 (85/group) individuals with early-stage T2D, participants will be randomized
to: (1) a Social Cognitive Theory-based behavioral lifestyle intervention that includes a one-size-fits-all
Mediterranean ADA diet (hereafter Standardized), (2) Standardized plus personalized dietary guidance to
minimize postprandial glycemic response to meals (hereafter Personalized), or (3) a Usual Care Control plus
(hereafter UCC). We will compare the groups in terms of mean amplitude of glycemic excursion (MAGE).
Hypothesis MAGEPersonalized< MAGEStandardized < MAGEUCC at 6 months. At each time point we will describe
between group differences in HbA1c, β-cell function, and the need to escalate the medication regimen. We also
will describe the impact of the interventions on alternative measures of glycemic variability (standard deviation,
Continuous Overall Net Glycemic Action, area under the curve, and frequency of out-of-range and seriously out-
of-range glucose values). We will explore the relative contribution of GV and HbA1c to observed changes in β-
cell function. The proposed study is an integrative scientific undertaking, reflecting the input of experts in nursing,
the behavioral sciences, computational biology, microbiome, mHealth technology, endocrinology, and nutrition
for the development of personalized behavioral counseling to minimize glycemic exposure and disease
progression in those with early-stage T2D.

Public health relevance
Project Narrative Limiting blood sugar peaks following meals is an important treatment goal in the management of type 2 diabetes, but evidence is mixed regarding the best dietary approach to achieve this goal. One-size-fits-all dietary recommendations may fail to limit blood sugar peaks because individuals differ greatly in their blood sugar responses to the very same foods. In this study we will compare two Mediterranean-type diabetic diets, one that has been standardized and one that has been personalized using a gut microbiome-based algorithm to limit blood sugar peaks following meals.